A novel role for endothelial mineralocorticoid receptors in obesity-associated cardiovascular disease in females

PROJECT SUMMARY
Obese premenopausal women are at higher risk for vascular disorders than obese men demonstrating that
obesity negates protective effects of female sex hormones, however, the underlying mechanisms are unknown.
The adipose-derived hormone leptin mediates hypertension in obese males and females, however, the
mechanistic pathways are sex-specific. Clinical data report better cardiovascular treatment outcomes in females
treated with mineralocorticoid receptor (MR) antagonists than males. In accordance, our lab published that leptin-
induced hypertension and endothelial dysfunction is mediated by the aldosterone-MR axis in females. In this
proposal we provide a number of novel preliminary data: 1. female mice are more sensitive to aldosterone-
induced endothelial dysfunction 2. endothelial-specific MR (ECMR) deletion and epithelial sodium channel
(ENaC) antagonism prevents leptin-induced endothelial impairment in females 3. endothelial cells of female
mice and humans express more ECMR than males 4. ovariectomy blunts ECMR expression, which is restored
by progesterone 5. ECMR expression correlates with progesterone levels in cycling and pregnant mice 6. protein
kinase C (PKC) inhibition prevents progesterone-stimulated ECMR expression 7. pregnant mice develop
pronounced endothelial dysfunction in response to leptin 8. placental ischemia induces elevated leptin and
aldosterone levels in pregnant rats. Therefore, we hypothesized that endothelial progesterone receptor activation
upregulates ECMR expression which mediates leptin-induced endothelial dysfunction and hypertension in
premenopausal and pregnant female mice. Three Specific Aims will rigorously test our hypothesis: 1 (K99):
progesterone upregulates endothelial mineralocorticoid receptor expression via endothelial progesterone
receptor activation, 2 (K99): endothelial mineralocorticoid receptors mediate leptin-induced endothelial
dysfunction and hypertension in female mice, 3 (R00 Independent): leptin-induced, aldosterone-mediated
activation of mineralocorticoid receptors contributes to endothelial dysfunction and hypertension in obese
preeclampsia. We will utilize novel transgenic mouse models (deficiency of endothelial-specific progesterone
receptors and ENaC), endothelial cell culture techniques investigating progesterone-mediated PKC mechanisms
and work with experts in the field to determine the regulation and functional relevance of ECMR in leptin-
mediated endothelial dysfunction and hypertension in premenopausal females. Furthermore, in the independent
phase, we will shift the approach utilizing the reduced uterine perfusion pressure mouse model of placental
ischemia to a groundbreaking study of the role of leptin in hypertensive pregnancy. The results of these studies
will further our knowledge of sex specific mechanisms of endothelial dysfunction and hypertension in females
and may lead to improved treatment strategies for obese pregnant and non-pregnant women. Furthermore, the
resources provided by mentors on this application, the environment at Augusta University and the training plan
enclosed will advance the applicant toward the goal of transitioning to independent researcher.

Public health relevance
PROJECT NARRATIVE The epidemic of obesity has drastically increased the burden of cardiovascular disease in women and clinical data shows that cardiovascular risk is higher in obese young women than in men. The proposed study utilizes a translational approach incorporating the use of transgenic animal models, advanced endothelial cell culture techniques, pharmacological strategies and collaborations with leaders in the field to rigorously test the hypothesis that increases in endothelial cell mineralocorticoid receptor expression underlie obesity-associated cardiovascular diseases in premenopausal females. This study will determine if mineralocorticoid receptor antagonists, which are currently available on the pharmaceutical market, may be a more efficacious treatment strategy for the prevention and treatment of cardiovascular diseases in premenopausal women.